Ocular MCMV latency and AMD-like pathology

Project Summary
Age-related macular degeneration (AMD) is the leading cause of irreversible visual dysfunction in older
individuals although its underlying causes have not been definitively elucidated. Human cytomegalovirus
(HCMV) infection could be a risk factor for progression of AMD since there is a significantly higher association
of elevated anti-HCMV IgG titers with neovascular AMD compared to either “dry” AMD or healthy controls
while HCMV DNA has been identified in choroid/RPE samples from human cadavers. Our published and
preliminary studies have shown that: (1) systemic neonatal murine cytomegalovirus (MCMV) infection of
both BALB/c and 129S1 mice spreads to the eye with subsequent establishment of latency in the
choroid/RPE; (2) retinal and choroidal pathologies, including deposits at both basal and apical aspects of the
RPE, CNV-like lesions, as well as degeneration of the choriocapillaris, RPE and photoreceptors occurs in
aged, infected BALB/c mice; (3) CNV lesions develop in eyes of aged 129S1 mice following systemic neonatal
MCMV infection; (4) hyperreflective lesions are present in the majority of infected, tamoxifen-inducible, RPE-
specific, SOD2 depleted 129S1 mice; and (5) RPE-specific, SOD2 depletion enhances spread of latent MCMV
to the RPE. Based on these findings we hypothesize that oxidative stress following light damage, activates
expression of ocular virus genes, which in turn, promotes production of inflammatory/angiogenic factors in
MCMV latently infected mice, thereby facilitating the development of AMD-like pathology, including CNV. Aim
1 will test the hypothesis that light damage and virus latency synergize to enhance the development of AMD-
like pathology. We will compare the development of AMD-like pathology in neonatally infected or uninfected,
aged BALB/c mice maintained under either low or regular-illumination. Aim 2 will test the hypothesis that
oxidative stress in the RPE and MCMV latency synergize to enhance development of AMD-like pathology.
We will induce mitochondrial oxidative stress by depletion of SOD2 in RPE cells and determine the effect of
oxidative stress on expression of MCMV latency-related genes, production of inflammatory angiogenic factors
and the development of AMD-like pathology. Aim 3 will test the hypothesis that release of angiogenic factors
by latently infected RPE cells is the mechanism by which latent ocular MCMV induces CNV. We will define
the location and identity of latently infected cells and quantify expression of MCMV latency-related and
inflammation/angiogenesis-associated genes in aged, latently infected eyes, both with and without CNV.
These studies will: 1) establish an in vivo mouse model of systemic neonatal MCMV infection and oxidative
stress, featuring the development of AMD-like pathologies; 2) increase our understanding of the synergy
between light damage, oxidative stress and virus latency in the development of AMD and 3) identify the
mechanism by which latent MCMV infection of the choroid, RPE and macrophages/microglia induce CNV.

Public health relevance
Project Narrative Human cytomegalovirus (HCMV) infection could be a risk factor for progression of AMD as a result of viral latency in the choroid/RPE, since there is a significantly higher association of anti-HCMV IgG titers with neovascular AMD and HCMV DNA was present in choroid/RPE samples from human cadavers. Our goal is to investigate the mechanism by which latent cytomegalovirus infection in the choroid/RPE contributes to the pathogenesis of AMD, thereby potentially opening new avenues for treatment. The proposed research is relevant to public health and NIH’s mission because increasing our understanding of the pathogenesis of AMD has the potential to yield new, more efficacious and less invasive treatment options.